High-Resolution Mapping of Bacterial Transcriptional Responses in Human-Associated Microbiota - Supplement

Project Summary
Our NIGMS-supported project aims to develop Precision Run-On and SEQuencing (PRO-seq) to capture
nascent transcripts in microbial communities. Whereas we often rely on the core to provide both fragment
analysis and Sanger sequencing for library preparation, these steps add considerable time to our workflow due
to long queues. Fragment analysis is required to determine whether there is sufficient amount of DNA for
sequencing and confirms that the size distribution is indicative of a diverse library rather than PCR artifacts
such as primer-dimers. Sanger sequencing is required for work with human gut microbiota, as these organisms
are rarely grown in strictly selective media, are often slow-growing, and therefore require confirmation to
ensure the strain cultures are free from contamination. Here, we request support for a ThermoFisher
SeqStudio which can perform both fragment analysis and Sanger sequencing, significantly streamlining our
design-build-test methods development process.

Public health relevance
Project Narrative Bacterial communities react to environmental stressors, the presence of oxygen in the gut, for example, by changing their transcriptional landscapes, and these responses underlie microbiome-related disorders such as inflammatory bowel disease (IBD), and colorectal cancer (CRC). Although RNAseq has been used to profile community function to obtain dynamic functional information not captured by metagenomic DNA sequencing alone, RNAseq is unable to capture real-time dynamics due to the varying stability of RNA, requires additional steps to remove ribosomal RNA, and isoften insensitive to short non-coding or modified RNA. We propose the development of Precision Run-On and SEQuencing (PRO-seq) as a promising method to capture transcriptional dynamics in cultured prokaryotes and in complex microbial communities, such as the human microbiome.